Decoding the rules that govern the coordination of the bacterial cell cycle

Abstract
Maintaining the integrity of the genome is essential to cell survival. As bacteria grow and divide, they must
coordinate numerous molecular machineries for each daughter cell to inherit an intact copy of the
chromosome. Miscoordination can be lethal, making these processes potential targets for novel antibiotics.
The Mera laboratory uses a systems approach to untangle the complex temporal and spatial coordination that
drive the progression of the bacterial cell cycle. The work combines classical genetics, biochemistry, and high-
resolution imaging to examine at the molecular level cell cycle coordination. The bacterial model system used
is Caulobacter crescentus, which exhibits a dimorphic life cycle. The project proposed has two main goals for
the next 5 years: (i) define mechanistic details for how the replication initiator DnaA with the partitioning system
ParABS coordinate the initiation of chromosome replication with centromere segregation, and (ii) uncover
mechanisms that bacteria use to coordinate chromosomal maintenance to the regulation of cell size and shape
over the cell cycle. Furthermore, the proposed work will provide important insights to how cells integrate
environmental information (e.g., nutrient availability) into the cell cycle network. The vision of the research
program in the Mera lab is to uncover the molecular rules that govern the coordination of the bacterial cell
cycle. The understanding of these fundamental rules has the potential to transform our ability to control the
growth of bacteria and to drive biomedical innovations.

Public health relevance
Bacteria play an important role in human health. This project aims to uncover the rules that govern bacterial growth. Understanding these rules will drive future innovations in biomedical and industrial fields.